Understanding Plasmodium vivax transmission networks through a novel microhaplotype and kinship analysis approach

Project Summary
When transmission decreases faster than a population loses immunity, subclinical or asymptomatic carriers
remain and can serve as a reservoir for forward transmission. Thus, reactive case detection (RCD), the following
up of individuals who reside nearby an index case, is being considered or is already implemented as a malaria
intervention in low transmission areas to detect and treat asymptomatic infections. RCD is rooted in the
observation that Plasmodium spp. infections tend to distribute in “hotspots” or spatially and temporally related
clusters. However, the contribution of imported infections, likely resulting from human travel, or relapse infections
to malaria transmission compromises the effectiveness of RCD as a malaria control tool in low transmission
areas. Transmission network analysis with high resolution genomic data can be used to assess the effectiveness
of RCD as an intervention strategy. Highly multiplexed amplicon sequencing (HM-AmpSeq) of highly polymorphic
microhaplotype markers is one powerful solution which could provide the genomic resolution needed for
transmission network analysis, while also being low cost, highly sensitive to detect minor infections, and allows
us to genotype point mutations of interest (e.g. drug tolerance markers) and resolve multilocus haplotypes in
complex infections under certain conditions. Transmission network analysis for Plasmodium spp. has been
hindered in part by genetic diversity being primarily driven by recombination coupled with common inbreeding
due to the closed mating environment within the vector, which alters expected kinship coefficients that vary by
epidemiological context. A novel approach to overcome these barriers is to generate known pedigrees using
genetic-epidemiologic simulations, which are used to accommodate uncertainty for kinship analysis. We have
developed a preliminary genome-wide P. vivax highly multiplexed microhaplotype panel using global genomic
data that has been successfully applied to dried blood spot samples with parasite densities as low as 32
parasites/µl. In Aim 1, we propose to further optimize this protocol to sequence samples with even lower parasite
densities by using promising enrichment strategies and strategically down selecting low performing markers. In
Aim 2, we will generate known pedigrees through genetic-epidemiologic simulations and apply the
microhaplotype panel and kinship analysis approach based on the likelihood ratio test statistic to P. vivax
samples collected in an RCD study to determine transmission networks. The overall objective of this project is
to develop an optimized genotyping and analytical method for reconstructing transmission chains of P. vivax and
apply the method to determine P. vivax transmission networks in Ethiopia. The novel approach developed
through this project could be broadly applied to improve our understanding of transmission networks for
assessing the effectiveness of potential malaria interventions.

Public health relevance
Project Narrative When malaria transmission decreases faster than a population loses immunity, asymptomatic carriers remain and can serve as important reservoirs for forward transmission. To make additional gains in malaria control, a better understanding of malaria transmission networks and the impact that potential reservoirs have on malaria transmission is needed. Highly multiplexed amplicon sequencing (HM-AmpSeq) of highly polymorphic microhaplotype markers coupled with a kinship analysis approach that accommodates uncertainty through the incorporation of genomic-epidemiologic simulations is a promising solution for studying malaria transmission networks to assess the effectiveness of malaria interventions.